PROLACTIN SECRETORY DYNAMICS IN POST-MENOPAUSAL FEMALES--EXOGENOUS ESTROGEN

The administration of physiological amounts of estradiol alters the rate, mass and/or duration of dopamine-modulated prolactin secretion in post-menopausal women.